Chromatin Organization Regulates Osteogenesis

SUMMARY
This new R01 builds on discoveries during the R37 period (2008-2018) that established epigenetic mechanisms
(miRNAs, histone modifications) regulating osteoblast differentiation. We characterized for the first time a
“signature” of specific histone modifications that are associated with dynamic changes in gene expression during
the temporal progression of osteogenesis. These histone modifications also predicted “enhancers”, which are
critical cis-regulatory elements that contribute to local gene expression. We now propose to examine the recently
recognized “super enhancer” domains (SEDs) that include regulatory elements for multiple transcription factors
that have emerged as key regulators of cell phenotypes. SEDs function in chromatin organization via long range
intra- and inter-chromosomal interactions that coordinate control of gene cohorts responsible for lineage
specification and distinct cell identity. Our preliminary studies have identified a subset of SEDs that we now
propose are putative “bone-essential super-enhancers” and candidates for the important decision stage of
commitment to osteogenesis from MSCs. We hypothesize that super-enhancer domains are differentially
activated from the undifferentiated MSC to the osteoblast commitment stage, and function to establish the
osteogenic phenotype by coordinately regulating gene networks and contributing to higher order chromatin
organization that supports cell identity. Our studies will in: Aim1- analyze the functional effects of prioritized SEDs
we have identified related to osteoblastogenesis and mature bone activities through directed inhibition and
activation of SEDs using CRISPR/Cas9 in MSCs; Aim 2- determine the chromosomal domains that interact
with SEDs to control multiple genes and networks that commit MSCs to the osteoblast phenotype through
chromatin organization; and Aim 3- demonstrate in mouse models that using CRISPR activated SEDs in MSCs
will stimulate bone formation.
Impact: These studies pioneer a new level of gene regulation for MSC lineage commitment to osteogenesis,
based on an emerging understanding of SED functions in other tissues but have been minimally studied in bone.
By characterizing SED mechanisms related to chromatin organization and stabilization in MSCs, we will discover
novel mechanisms of multi-dimensional coordinate control of transcriptional hubs and protein complexes within
an SED that is responsible for establishing commitment to the osteoblast phenotype. Importantly, knowledge of
the chromatin organization that stabilizes the osteogenic phenotype impacts on future novel treatment strategies
for skeletal disorders.

Public health relevance
NARRATIVE Newly identified regulatory elements across the genome designated as “super enhancer domains” (SEDs) have highly specialized functions in controlling commitment of stem cells to development of a specific cell lineage. The proposed research will, for the first time, characterize SEDs that establish the bone forming osteoblast lineage. These novel genomic regions provide the basis for development of strategies in future studies to regenerate bone tissue in skeletal disorders.